Multiomics Core

MULTIOMICS MODULE Summary The Multiomics (MO) module is a new module that allows MVRC researchers to perform cutting- edge high throughput analyses, including mass spectrometry, metabolomics and lipidomics. Specific Aims are: 1) To provide extensive high throughput analyses including mass spectrometry, metabolomics, metabolic flux determinations, ligandomics and lipidomics, 2) To assist investigators with sample preparation specialized for small sample size and laboratory protocols tailored for parts of eye tissue and to provide training in operating the equipment, 3) To provide support and training in analytic and visualization tools for the large data sets generated by these analyses. This module replaces and refines the previous “Shared Equipment” module and includes multiomics technologies only. The use of the specialized equipment is also complemented by integration of multi-omics analyses, machine-learning and computational biology assistance. The main rationale for the module is that it allows us to house a vast array of high-end equipment in one location with dedicated technical staff for using and maintaining the equipment, in order to maximize use of these new technologies in generating data for existing research projects and for obtaining pilot data for new grant applications. Additionally, housing common reagents and internal and external standards with a shared electronic dashboard enables effective utilization of resources, and promotes sharing reagents, protocols and cross-fertilization of ideas. This module supports innovative research and will enable analysis of global ocular metabolic changes, including metabolic flux determinations. Progressive and complex diseases are now recognized to be associated with incremental changes in the tangents of metabolic concentrations and disruptions in early metabolite-protein interactions can change the course of disease. Therefore, information derived from multiomics can be innovatively utilized to tailor intervention strategies. This module thus sits on the very forefront of such strategies. 1